Using a Health Disparity Research Framework to examine mechanisms linking Obstructive Sleep Apnea with higher Alzheimer’s disease risk in older Blacks/African-Americans

PROJECT ABSTRACT/SUMMARY
Blacks/African-Americans (blacks) have two times the risk of developing Alzheimer’s disease (AD) compared to
non-Hispanic whites (whites), in part attributable to the higher prevalence of vascular risk factors. Examining
other risk factors and delineating pathological mechanisms associated with this higher AD-risk in older blacks is
a critical initial step needed to optimize patient care paradigms. Obstructive sleep apnea (OSA) is one such risk
factor. Notably, blacks have a higher burden of OSA with excessive daytime sleepiness (EDS), which is associated
with longitudinal amyloid-PET uptake. OSA is associated with decreased non rapid eye movement (NREM) slow
wave sleep/activity (SWS/SWA) and increased inflammation, both of which affect amyloid and tau pathology.
NREM SWS/SWA and inflammation are also associated with changes in cognition in late-life, and are more
burdensome in blacks. The current proposal will utilize a health disparities research framework related to aging
to: (i) investigate within and between race effects of OSA on AD pathology. (ii) Identify decreased NREM
SWS/SWA and increased inflammation as potential intermediate mechanisms linking OSA and AD. (iii)
Examine whether socio-structural determinants of health (SDOH) can help explain racial heterogeneity in OSA-
AD outcomes. Our
neurodegeneration,
central hypothesis is that black OSA subjects will exhibit higher tau and greater
as well as reduced NREM SWS/SWA and increased inflammation compared to white OSA
subjects, in the context of amyloid burden. Furthermore, we hypothesize SDOH (i.e., environmental, socio-
structural, and behavioral factors) and vascular risk will mediate racial heterogeneity in OSA-AD outcomes. We
will test our central hypothesis in a sample of 300 community-dwelling cognitively normal (CN) subjects; ages
55-85 matched on race (2:1), age and sex, and balanced by education, income and BMI. Subjects will include 150
controls (100 blacks & 50 whites), and 150 newly diagnosed OSA subjects with EDS (100 blacks & 50 whites).
This proposal will recruit from the community, 125 new black subjects [80 OSA and 45 controls] and leverage
existing data and resources in 175 (75 blacks [20 OSA and 55 controls] & 100 whites [50 OSA and 50 controls])
community-dwelling CN subjects with similar eligibility criteria, from NYU Alzheimer’s Disease Research Center
and two-affiliated ongoing NIH supported R01 studies (R01AG056031 and R01AG056531). Subjects will
undergo 2 nights of at-home sleep monitoring for OSA, followed by 5 days of actigraphy and sleep logs. Clinical
visits will include full clinical evaluation, neuropsychological tests and clinical labs on visit 1; 1 night of nocturnal
polysomnography (NPSG) recording on visit 2; neuroimaging measures of vascular burden, amyloid (18F-
florbetaben) and tau (18F-PI2620) PET-MRI on visits 3 and 4 respectively, at baseline and at 2.5 years follow-up.
Importantly, we will prioritize acquisition of SDOH data to elucidate disease mechanisms to aid future discovery
of novel AD prevention targets e.g. targeting stress management, inflammation and sleep quality in OSA.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH There is great need to diversify Alzheimer’s disease (AD) and Alzheimer’s disease-related dementias (ADRD) research cohorts, improve methods and tools for conducting health disparities research related to AD/ADRD, and examine other risk factors like obstructive sleep apnea (OSA), associated with higher AD-risk in older blacks, as this is critically needed to optimize patient care paradigms. In this innovative hypothesis-driven study, we will utilize a health disparities research framework related to aging to examine whether socio-structural determinants of health (SDOH) can help explain racial/ethnic heterogeneity in OSA-AD outcomes. The significance and impact of this proposal is strengthened by enrollment of a unique population of older blacks in which we will obtain neuroimaging measures of vascular burden, amyloid, and tau as well as nocturnal polysomnography (NPSG) recordings, and prioritize acquisition of SDOH data to elucidate disease mechanisms to aid future discovery of novel AD prevention targets and disease-modifying treatments.